Muscle power training to improve depression and walking post-stroke

Abstract
Depression is the most common neuropsychiatric manifestation following stroke and current treatments are
largely ineffective. Depression has both direct and indirect effects on response to rehabilitation, thus subjects
with post-stroke depression (PSD) are routinely excluded from clinical trials and treatment options are extremely
limited. We propose to determine the impact of a novel, high-intensity resistance training program, Post-stroke
Optimization of Walking using Explosive Resistance (POWER) training, on post-stroke depressive symptoms.
Further, we will determine if depression limits training-induced improvements in muscular and locomotor
function. This project is based on the premise that depression negatively affects the potential for neuroplastic
changes to occur in response to treatment such that rehabilitation may not produce the same adaptations that
it does in non-depressed individuals. We propose that effective treatment for PSD would result in a virtuous
cycle where reducing depression enhances neuroplastic changes, thereby facilitating functional gains. That is,
effectively treating depression will make the individual better able to recover from stroke. Furthermore, in
addition to its beneficial effects on depression, POWER training is known to improve post-stroke walking, thus
providing an attractive option for treating depression as well as an established vehicle to study the effects of
PSD on response to rehabilitation. The experiments proposed as part of this project are designed to address
critical questions related to 1) the effects of POWER training on depressive symptoms; 2) the potential for
PSD to limit improvements following training; and 3) the interaction between improvements in depression and
increases in walking function. Successful completion of this project will provide a foundation for larger scale
trials to determine dosing parameters as well as establish therapeutic effectiveness of POWER training on
post-stroke depression as well as identify the mechanisms that may be responsible for the changes that occur
in response to treatment.

Public health relevance
Narrative We will study the effects of a 12 week strength training program on individuals who have had a stroke and are depressed to see if this type of exercise training helps treat depression and improves walking function. Our goal is to use the information collected in this study to help design treatments for people who have had a stroke that will help with many of the common consequences of stroke, including depression, muscle weakness and slow walking. Progress toward overcoming some of these issues would be incredibly valuable to any person who has had a stroke and theirfamilies.